Flow Cytometry

Use of Core by PI - Fellow (or staff/student) NHLBI Barrett - Melenhorst Boehm Ma Burg - Williams Childs Berg -Pantin Donaldson - Aryal - Eyster - Cole Dunbar -Barese -Donahue - Larochelle -Metais Greene -Chandris -Zhao Hwang -Lago -Wang Knepper Gonzales Kotin Li Kruth Anzinger Leonard - Kashyap - Liao - Spolski - Wan - Lin Levine -Fredrikkson -Yao Michelson Busser Mohuiddin Singh Moss Cai Pacheco Kang Mukoyama -Nalbandian -Lee Murphy Nguyen Pohl -Chakrobarty -Chea -Bourdi Puertollana Vergarajauregui Remaley -Bocharov -Vickers -Rousset Rodgers Aerbajinase Roll-Mecak -Sunyer Sack -Stevens -Webster Tisdale Mitchell Waterman -Kuo -Paspera -Thievessen Xu -Linask -Ren Young -Chen -Zhi -Feng Zhao -Cui -Kraushaar -Maunakea -Northrup -Tang NIDDK Deng Vasquez Reherman Park Simonds Sharrett -Zhang Tarbell -Kilby -Kretz Wank Liu NINDS Hallenback Bogoslovsky NICHD Westphal - Francis